DETERMINANTS OF DISABILITY IN OLDER CORONARY PATIENTS

Disability rates are extremely high in older coronary patients. Determinants of disability were studied in 44 patients with established coronary heart disease over the age of 65 years (mean 74 years). Disability score was determined from the physical function component of the Medical Outcome Study Questionnaire. Independent variables included peak aerobic capacity, rest and exercise echocardiography, body composition measures by dual x-ray absorptiometry, handgrip and leg extensor strength and a depression score.